A system for spatiotemporal gene inactivation

DESCRIPTION (provided by Principal Investigator): This application aims to provide zebrafish researchers with conditional mutations for determining stage- and tissue-specific gene function. The zebrafish has become a popular model for functional analysis of genes. Although there are several gene inactivation methods in zebrafish, they all abolish gene function in all cells at all time, often concealing later or less pronounced functions. Determining temporal and spatial specific gene function requires conditional alleles that inactivate genes precisely in the stage and tissue of interest, usually by a site-specific recombinase. In zebrafish, however, conditional alleles are not currently available and transgenic lines with stage- and tissue-specific expression of a site-specific recombinase are very rare. This application aims to fill these voids and generate conditional alleles and transgenic recombinase lines for stage- and tissue-specific recombination in somatic cells. Our strategy for generating conditional mutations is to use gene trap mutagenesis. This approach takes advantage of the dependence of gene trap mutations on a strong 3' terminal exon in the right orientation and stable inversion of the gene trap using recombinase-catalyzed flip and excision (FlEx). We have constructed an invertible, bidirectional gene trap cassette with asymmetric mutagenicity and have used it to generate gene trap mutations. We have demonstrated that Cre and Flp can efficiently invert the gene trap cassette and switch it between mutagenic and non-mutagenic states. To make use of the conditional allele, we have generated tissue-specific Cre and tamoxifen-dependent Cre lines. We propose to expand the production of conditional alleles and transgenic recombinase lines as a community resource. Aim 1 is to generate a public collection of annotated conditional alleles. We will identify 500 annotated gene trap insertion lines containing a conditional cassette and deposit them in ZIRC for public distribution. For each insertion, we will determine the integration site and the affected gene, as well as document the expression pattern at 2 stages. We will analyze 3 selected insertions that are allelic to published mutations to further confirm utilities of the alleles. Aim 2 is to generate a collection of recombinase-expressing lines for stage- and tissue-specific recombination. We will generate a transgenic line for stage-specific recombination using Tg(hsp70l:CreERT2) and Tg(hsp70l:ERT2CreERT2) constructs. We will generate Cre- or tamoxifen-inducible Cre-expressing lines using characterized promoters, as well as targeted integration at gene trap sites with highly tissue-specific expression. The specificity of these lines will be characterized and 20 selected lines will be deposited at ZIRC. The application addresses several of the stated objectives of PAR 08- 139 and should broaden the use of zebrafish in understanding genetic basis of human diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: To better define gene function, we propose to establish a system for spatiotemporal specific gene inactivation and targeted gene replacement. Components of the system will be deposited at the Zebrafish International Resource Center for public distribution. Because most zebrafish genes have a human ortholog, the system will help understand genetic bases of human physiology and disease. To better define gene function, we propose to establish a system for spatiotemporal specific gene inactivation and targeted gene replacement. Components of the system will be deposited at the Zebrafish International Resource Center for public distribution. Because most zebrafish genes have a human ortholog, the system will help understand genetic bases of human physiology and disease. __SpecificAimsTextDelimiter__ A. Specific Aims This application aims to provide zebrafish researchers with conditional mutations for determining stage- and tissue-specific gene function. The zebrafish has become a popular model for functional analysis of genes. Although there are several gene inactivation methods in zebrafish, they all abolish gene function in every cell at all times, often concealing later, tissue-specific, or less pronounced functions. Determining temporal and spatial specific gene function requires conditional alleles that inactivate genes precisely in the stage and tissue of interest, usually by a site-specific recombinase. In zebrafish, however, conditional alleles are not currently available and transgenic lines with stage- and tissue-specific expression of a site-specific recombinase are very rare. This application aims to fill these voids and generate conditional alleles and transgenic recombinase lines for stage- and tissue-specific recombination in somatic cells. Our strategy for generating conditional mutations is to use gene trap mutagenesis (Fig 1). This approach takes advantage of the dependence of gene trap mutations on a strong 3' terminal exon in the right orientation and stable inversion of the gene trap using recombinase-catalyzed flip and excision (FlEx). We have constructed an invertible, bidirectional gene trap cassette with asymmetric mutagenicity and have used it to generate gene trap mutations. We have demonstrated that Cre and Flp recombinases can efficiently invert the gene trap cassette and switch it between mutagenic and non-mutagenic states. To make use of the conditional alleles, we have generated tissue-specific Cre and tamoxifen-dependent Cre lines. We propose to expand the production of conditional alleles and transgenic recombinase lines as a community resource, as well as identifying mutations in the genes of our own interest. A P mutagenic benign germline Flp RNA B P benign mutagenic somatic Cre C P mutagenic benign GOI GOI GOI Fig 1. Schematic of the proposed insertional alleles and their use for conditional and reversible gene inactivation. The initial allele is depicted in A. The mutagenic gene trap consists of a strong splice acceptor and a strong polyA signal. The benign orientation has a non-mutagenic gene trap. Stable inversion by Flp or Cre through flip and excision (FlEx) changes the mutagenicity of the cassette (B,C). P, promoter; GOI, gene of interest; Brown/organe arrowheads, heterospecific Cre targets; blue/cyan arrowheads, heterospecific Flp targets. Aim 1. To generate a public collection of annotated conditional alleles. We will identify and annotate 500 gene trap insertion lines containing a conditional cassette and deposit them in the Zebrafish International Resource Cente (ZIRC) for public distribution. For each insertion, the integration site and the affected gene will be identified, and the expression pattern at 2 stages will be documented. In addition, 3 selected insertions that are allelic to known mutations will be compared to published data. Furthermore, experiments will be performed to demonstrate other functionalities of these alleles including tissue- specific gene inactivation, genetic mosaic analysis, and reading frame correction of out-of-frame gene trap insertions. Aim 2. To generate a collection of recombinase-expressing lines for stage- and tissue-specific recombination. We will generate 20 high quality Cre and tamoxifen-dependent Cre lines for spatial- and temporal- specific recombination. Tg(hsp70l:CreERT2) and Tg(hsp70l:ERT2CreERT2) lines will be generated for stage-specific global recombination. Tissue-specific promoters with characterized expression patterns will be used to generate Cre-expressing lines for tissue-specific recombination. These promoters will also be used to generate tamoxifen-dependent Cre-expressing lines for temporal and spatial-specific recombination. These lines will be deposited at ZIRC for public distribution. The application addresses several of the stated objectives of PAR 08-139. The collection of conditional alleles and the accompanying recombinase lines should allow more sophisticated analyses of gene function beyond development, and therefore broaden the use of zebrafish in understanding genetic basis of human diseases.